Multiregional Neuronal Computations Underlying Rapid and Flexible Visual Categorical Decisions

Summary and Relevance of Proposed Research
Humans have a remarkable capacity to learn to recognize and make decisions about incoming visual stimuli.
This ability, which is disrupted by brain-based diseases and conditions such as Alzheimer’s disease,
schizophrenia, stroke, and attention deficit disorder, is critical because it allows us to learn about the meaning
of the stimuli that we encounter, and it enables us to make appropriate decisions. The neuronal computations
which underlie rapid and flexible visually-based decisions involve interactions among neuronal populations
both within and between brain regions spanning visual, cognitive, and motor areas. To understand how
coordinated neuronal activity mediated decision related neuronal computations, this project employs a close
interaction between experimental and theoretical modeling approaches. The experimental work employs large-
scale neuronal population recording techniques to monitor the activity in three interconnected brain regions—
posterior parietal cortex (PPC), frontal eye field (FEF), and superior colliculus (SC)—during visual decision
making tasks. Experiments also employ reversible inactivation of each brain region to causally test
hypotheses. The theoretical work develops novel theories of neuronal population function directly inspired by
the experimental data and inactivation results, in order to determine the patterns of neuronal activity and
interactions within and between regions which support computations underlying task performance.
While much is known about how the brain processes visual features (such as color, orientation, and direction
of motion), less is known about how the brain learns and represents the meaning, or category, of stimuli. A
greater understanding of visual categorization is critical for addressing many brain diseases and conditions
(e.g. stroke, Alzheimer’s disease, attention deficit disorder, schizophrenia, and stroke) that leave patients
impaired in everyday tasks that require visual learning, recognition and/or evaluating and responding
appropriately to sensory information. The long-term goal of this project is to guide the next generation of
treatments for these brain-based diseases and disorders by helping to develop a detailed understanding of the
brain mechanisms that underlie learning, memory and recognition. These studies also have relevance for
understanding and addressing learning disabilities, such as attention deficit disorder and dyslexia, which affect
a substantial fraction of school age children and young adults. Thus, a detailed understanding of the basic
brain mechanisms of categorical decisions and attention will likely give important insights into the causes and
potential treatments for disorders involving these cognitive and perceptual abilities.

Public health relevance
Project Narrative Our ability to learn to make rapid categorical decisions about visual stimuli is essential for planning and carrying out successful behaviors in response to our surroundings—functions that are frequently disrupted by brain diseases and conditions such as stroke, schizophrenia and Alzheimer’s disease. This project conducts large scale recordings of neural activity in the prefrontal cortex, parietal cortex, and superior colliculus during rapid visual categorical decisions in order to understand the neuronal computations underlying decision making. The project also develops novel theoretical neural network models which will provide mechanistic insights into how activity across interconnected regions enact computations underlying categorical decisions.